Targeting S-adenosylmethionine decarboxylase for HAT drug discovery

DESCRIPTION (provided by applicant): Human African trypanosomiasis (HAT) is caused by the parasitic protozoan, Trypanosoma brucei. HAT is listed as a WHO Category 1 disease (emerging and uncontrolled) that exerts a large burden in both health and economic costs to the endemic regions in Africa. The disease is fatal unless treated and current therapies suffer from high toxicity and difficult treatment regimes. Furthermore none of the current drugs are effective against both species and stages of the disease. There is a great need to translate recent advances in the understanding of the basic biology of the parasite into new safe, effective drugs that have activity against all forms of the parasite, and which can be easily administered. Polyamines are essential metabolites that are required for cell growth. The polyamine biosynthetic enzymes, including ornithine decarboxylase (ODC) and S-adenosylmethionine decarboxylase (AdoMetDC) are essential to the parasite. a-difluoromethyornithine (DFMO), a suicide inhibitor of ODC, is the frontline treatment for late-stage T. gambiense, validating polyamine biosynthesis as a drug target in the parasite. Our group has systematically explored the potential for other enzymes in the polyamine biosynthetic pathway to be validated for the discovery of new anti-trypanosomal agents, leading to the validation of AdoMetDC as a highly promising target for HAT drug discovery. We demonstrated that AdoMetDC is essential to blood stage T. brucei parasites using genetic approaches and we discovered that the enzyme is regulated by a unique mechanism not found in mammalian cells. Starting from a previously identified human AdoMetDC inhibitor (MDL 73811) we identified new compounds (eg Genz 644131) that are potent irreversible inhibitors of T. brucei AdoMetDC, with nM activity against parasites in vitro, and that are curative in early stage mouse infection models. Genz 644131 however is not effective against late stage infection models in mice. Our objectives are to identify novel inhibitors of T. brucei AdoMetDC without this liability, and to undertake a lead optimization program around these inhibitors to identify a preclinical candidate with the potential to treat both species and both stages of HAT. We have developed a two-part strategy that should maximize the chances that we can achieve this goal. In Aim 1 we will undertake additional lead optimization work on the Genz 644131 series with the goal of identifying compounds with improved brain penetration and activity in the late stage model. In Aim 2 we will conduct a high throughput screen (HTS) to identify novel T. brucei AdoMetDC inhibitors. Compounds identified from the HTS will be validated, and two of the best series will be selected based on a target selection matrix that includes potency, selectivity, activity in whole cell assays and suitable ADME properties. An iterative lead optimization program of the top series will be prosecuted in Aim 3. In Aim 4 mechanism of action and resistance studies will be undertaken, providing supporting data on suitability of the identified candidates. DNDi has agreed to serve as program consultants on this project.

Public health relevance
Public Health Relevance: Human African sleeping sickness (HAT) is a fatal insect borne disease caused by a parasitic pathogen that leads to death if untreated. Current drug therapies have high toxicity and are difficult to administer in rural African settings where the disease is endemic. The goal of this proposal is to identify novel, safe and easily administered compounds that cure both early and late stage infections of this disease in animal models, resulting in the nomination of a preclinical development candidate for the treatment of HAT by the completion of the 5-year fund period. Project Narrative. Human African sleeping sickness (HAT) is a fatal insect borne disease caused by a parasitic pathogen that leads to death if untreated. Current drug therapies have high toxicity and are difficult to administer in rural African settings where the disease is endemic. The goal of this proposal is to identify novel, safe and easily administered compounds that cure both early and late stage infections of this disease in animal models, resulting in the nomination of a preclinical development candidate for the treatment of HAT by the completion of the 5-year fund period. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Human African trypanosomiasis (HAT) is caused by the parasitic protozoan, Trypanosoma brucei. Fifty million people are at risk for the disease, which is fatal if not treated. Current drug therapies are inadequate, and are limited by toxicity, difficult treatment regimes and growing number of treatment failures. Polyamines are small organic cations that are required for cell growth. The polyamine biosynthetic enzymes, including ornithine decarboxylase (ODC) and S-adenosylmethionine decarboxylase (AdoMetDC) have been extensively studied as targets for anti-proliferative chemotherapy. Notably, the ODC inhibitor eflornithine is now considered a frontline treatment for HAT, validating polyamine biosynthesis as a drug target in this disease. However, eflornithine has significant limitations in the clinical setting. Our studies to identify additional targets in the pathway have led to the validation of AdoMetDC as a promising target for the identification of new HAT chemotherapy. We demonstrated that AdoMetDC is essential to blood stage T. brucei parasites using genetic approaches and we discovered that the enzyme is regulated by a unique mechanism not found in mammalian cells. Starting from a previously identified human AdoMetDC inhibitor (MDL 73811) we identified new compounds,eg Genz 644131, in this class that are potent irreversible inhibitors of T. brucei AdoMetDC, with low nM activity against parasites in vitro, and the ability to cure early stage infection in mice. No discovery program for AdoMetDC has started with the goal of targeting the T. brucei enzyme, and all current inhibitors have arisen from the human AdoMetDC program. The problems with the current classes of AdoMetDC inhibitors are 2-fold: 1) reversible inhibitors developed against human AdoMetDC have poorer activity against the T. brucei enzyme, and 2) while the MDL 73811 analogs we identified cure early stage infection, they do not cross the blood brain barrier sufficiently well to be effective against late stage infection in a mouse model. Our objectives are to identify novel inhibitors of T. brucei AdoMetDC that overcome these shortcomings, and to undertake a lead optimization program to identify, a preclinical candidate with the potential to treat both species (T.b. gambiense and T.b. rhodesiense) and both stages of HAT, in consultation with DNDi. Aim 1. Lead Optimization of the Genz 644131 series to identify compounds active in late stage HAT a) A limited medicinal chemistry effort (up to 20 analogs) around Genz 644131 will be conducted with the goal to improve brain penetration by increasing lipophilicity and reducing polar surface area. b) Compounds will be tested and advanced based on the criteria described in Aim 3b-3d. Aim 2. Identify novel chemical classes of reversible T. brucei AdoMetDC inhibitors by HTS a) T. brucei AdoMetDC Inhibitors will be identified by screening of a 260,000 small molecule compound library housed at Genzyme using a colorometric coupled enzyme assay. b) Identified hits will be validated (dose response, purity/mass conformation, reassay by alternative assay) and counter screened against human AdoMetDC and T. brucei parasites in whole cell assays. c) Preliminary SAR will be developed for 4-6 of the validated hit series using commercially available analogs and chemical synthesis if required. d) The top two HTS series will be advanced into the Hit-to-Lead expansion with the goal of identifying compounds with suitable ADME properties to show activity in mouse models of HAT. Aim 3. Lead optimization of the selected HTS series to identify a preclinical candidate a) An iterative medicinal chemistry effort will be undertaken on lead candidates from the HTS program b) Compounds will advance through a testing cascade that includes evaluation of potency in enzyme- based and cell-based assays, species selectivity, metabolic stability, in vivo pharmacokinetics including brain penetration, and in vivo efficacy in mouse models of first and second stage disease. c) Pilot safety assessment will be done for representative compounds: to include ames, hERG ion channel, Cerep panel of receptors, ions and transports. d) Compounds meeting our advancement criteria will be selected for in vitro safety pharmacology and Non-GLP 7 day rodent exploratory toxicology studies with the goal identification of a preclinical candidate. Aim 4. Evaluate inhibitor mechanism of action and potential for drug resistance at the cellular level a) Select compounds will be evaluated to determine if they act through inhibition of polyamine biosynthesis using a combination of polyamine pool analysis, profiling of expression patterns of pathway enzymes and genetic rescue approaches. b) Compounds will be evaluated for sensitivity against a broad range of parasite strains, including strains resistant to current HAT drugs. c) The potential for drug resistance to develop will be assessed by step-wise selection protocols and the mechanism underlying any drug resistant clones will be studied.